Linking trigeminal and visual sensitivity in migraine

Project Summary
Hypersensitivity is a canonical feature of migraine, with pain from light (photophobia) and touch (facial
allodynia) present during the ictal headache phase, and sometimes the inter-ictal period as well. Headache
and facial allodynia appear to reﬂect potentiation of trigeminal signals in migraine. This same mechanism may
account for photophobia as well. A subset of retinal ganglion cells express the photopigment melanopsin,
rendering them intrinsically photosensitive (the “ipRGCs”). Rodent studies show that these cells project to
thalamic and brainstem sites that also receive somatosensory input from the trigeminal nerve, providing a point
of neural interaction of somatic and visual signals. Can this promising biological model—derived in animal
studies—account for the properties of sensory symptoms in human migraine? To explore this question, we
require a quantitative hypothesis testing framework, and a reproducible, objective measure of trigeminal
sensitivity to supra-threshold stimuli. We propose to create this experimental platform and test key elements of
the trigeminal hypersensitivity model. We have modiﬁed a commercial “blink reﬂexometer” to measure
parameters of the corneal blink reﬂex to graded air-puff stimulation. We will test (Aim 1) if people with migraine
and inter-ictal photophobia, as compared to headache-free controls, have a systematic, group difference in the
slope of this reﬂexive sensitivity function or in a report of discomfort. Further, we will determine (Aim 2) if
graded variation in a simultaneous light stimulus interacts with air-puff intensity in the production of these
explicit and reﬂexive responses, thereby testing for anatomical convergence of visual and trigeminal somatic
signals.

Public health relevance
Project Narrative Migraine headache is frequently accompanied by debilitating changes in sensitivity to touch (allodynia) and light (photophobia). In this project we will measure the blink reflex in people with and without migraine, and test if this response differs between the groups, and if concurrent light stimulation alters sensitivity. A positive result would support the hypothesis that a common change in the trigeminal system of the brainstem is at work in sensory alteration in migraine.